Cancer Control Research Program

PROJECT SUMMARY: CANCER CONTROL RESEARCH PROGRAM
The Sylvester Comprehensive Cancer Center (Sylvester) Cancer Control (CC) Research Program is co-led by
Frank J. Penedo, PhD, and Tracy E. Crane, PhD, who offer complementary expertise across the cancer
control continuum from prevention to survivorship. CC advances cancer control science, particularly for the
diverse communities comprising South Florida (SoFL), Sylvester’s four-county catchment area (CA). These
efforts strategically align with the program’s two specific aims 1) identify and characterize multilevel
determinants of cancer etiology, risk, and outcomes from prevention to survivorship among diverse
populations; and 2) design and test innovative interventions to reduce cancer disparities and improve
outcomes across the cancer control continuum. With Sylvester investments, CC has continued to mature,
growing in membership, scientific productivity, and scope in alignment with Sylvester’s 2019-2023 Strategic
Plan. Targeted faculty recruitment has added expertise in social epidemiology, cancer care delivery, cancer
survivorship, and lifestyle medicine (health behavior) research. The program has achieved key milestones
including receiving a cancer equity T32 training grant, creating a Hispanic/Latino(a) (H/L) cancer survivorship
cohort, and launching several transdisciplinary, multisite, and innovative CA-relevant projects. CC has grown to
include 47 members from four University of Miami Colleges and Schools (Schools of Medicine, Music,
Communications, and the College of Arts and Sciences), representing 12 departments. CC has $7.4M in
annual direct peer-reviewed, cancer-related extramural funding—an increase of over $1M annually since the
prior submission, including $2.9M from the National Cancer Institute (NCI). Over the reporting period (6/1/2018-
5/31/2023), program members published 817 peer-reviewed, cancer-relevant papers; 24% (n=200) were intra-
programmatic and 15% (n=126) inter-programmatic, 18% (n=144) were in journals with impact factors ≥10, and
73% (n=599) were published with collaborators from other institutions. Support for faculty recruits totaled
$11.8M and Sylvester Intramural Funding Program (IFP) investments of $2.1M to CC members resulted in
$6.9M of external funding, over a 3-fold return on investment. Grounded in the unique diversity of Sylvester’s
CA, CC has characterized a greater appreciation of the critical heterogeneity of cancer risk, prevalence, and
outcomes in disparate communities (e.g., Caribbean Black, H/Ls) and developed novel interventions that have
led to practice-changing impact across the cancer continuum. Sylvester’s investments in key research
infrastructure, most notably the Behavioral and Community-Based Research Shared Resource, and
Sylvester’s Office of Outreach and Engagement ensure input from key community stakeholders to address
community priorities in cancer control. CC continues to develop a highly collaborative and engaged
membership that forms a robust, sustainable, and comprehensive program that advances Sylvester’s mission
among vulnerable racial, ethnic, occupational, and aging populations in SoFL and beyond.